Infectious Diseases Across Scales Training Program

Project Summary
Infectious diseases continue to be a major cause of human suffering and mortality. While much research and
training has focused on studying infectious disease at a single scale (e.g. within hosts or at the population level),
a major challenge in the control of infectious diseases is that they routinely operate across scales. Specifically,
the interactions between host immune molecules and pathogens determine their transmission at the population
level, which in turn determines the spread of diseases across regions; in addition, a major feature of emerging
infectious diseases is that they infect a wide variety of non-human hosts, complicating their control.
Consequently, in order to effectively understand and control infectious diseases, researchers require integrated
training in interdisciplinary, cross-scale approaches that span the full range of biological organization, from
molecules to ecosystems. The proposed Infectious Diseases Across Scales Training Program (IDASTP) at
Emory University is designed to provide such inter-disciplinary training. This program will partner with 30 faculty
from multiple schools and departments to train a total of four graduate students each year, with each student
obtaining two years of training. Students will be recruited from a total of ~19 training-eligible students in three
graduate programs with exceptional strengths in infectious disease research related to immunology, population
biology and public health. The most important component of training in these programs is research, first as part
of laboratory rotations, then as part of the dissertation project. IDASTP trainees will obtain integrated training in
cross-scale infectious disease research through interdisciplinary curricula and a course Integrating Study and
Control of Infectious Disease Across Scales. They will also participate in a biweekly Infectious Disease Forum
and an Annual Infectious Disease Symposium, presented by local and external infectious disease experts.
Seminars and symposium will focus on the fundamentals of cross-scale interactions, control applications and
career development, providing workshops and exposing students to cross-disciplinary career opportunities in
academic and non-academic settings. Further integration of student training across scales is ensured by the
formation of dissertation committees that include faculty with expertise in infectious disease research at different
scales. The overall objective of this training program is to produce broadly trained and competitive scientists who
use interdisciplinary and cross-scale approaches to better study and control infectious disease. Graduates from
this program will have acquired: broad knowledge of cross-scale disease dynamics; in-depth knowledge of their
field of research; the ability to effectively develop research projects, grant proposals, presentations and
publications; and an appreciation of the career trajectories available to infectious disease doctorates. The
implementation of this program at Emory University will attract and retain top-tier students and produce new
cohorts of specialists who can effectively tackle infectious diseases by utilizing cross-disciplinary tool sets.

Public health relevance
Project Narrative This application requests funds to support the training of four pre-doctoral students per year in a newly developed Infectious Diseases Across Scales Training Program at Emory University. Thirty training faculty from three graduate programs with exceptional strengths in infectious disease research will provide students with training opportunities across a wide range of biological scales, ranging from the immune molecules that dictate interactions between human host cells and pathogens, to the ecosystems in which humans share their pathogens with vectors and other animals. The over-arching goal of this training program is to provide students with the inter-disciplinary and cross-cutting skills and tools to better understand and control infectious disease, and thereby increase healthcare in the United States and beyond.